Identifying Key Structural Interactions in Heparan Sulfate-Protein Complexes

Project Summary
Glycosaminoglycans (GAGs), such as heparan sulfate (HS), are important components of the extracellular
matrix of all cells. The extraordinary structural diversity of GAGs enables them to interact with a wide variety of
biological molecules, but primarily proteins, to modulate biological processes, such as cell adhesion, tissue
repair, coagulation, and immune response, among many others. Additionally, a number of different viruses,
including HIV-1, initiate infection of cells by binding to cell surface GAGs. Unfortunately, the diversity of
potential binding motifs in GAG sequences has made identification of relevant sequences challenging. In
particular, heparan sulfate (HS) is the most structurally diverse, with sixteen unique disaccharide configurations
and 256 unique tetrasaccharide configurations. Significant progress has been made in recent years developing
libraries of synthetic HS oligomers, allowing for detailed experimental structural studies of HS-protein
complexes. Understanding the structural basis of these interactions is key to drug development and the HS
binding protein-HS (HSBP-HS) interaction studies to date have been either non-structural or computational.
The overall goal of this project is to utilize these recently developed synthetic HS libraries and NMR-based
structural models to identify key interactions. HIV-1 p17 will be used for initial studies because it is very
important in many stages of the life cycle of HIV-1. Heparan sulfate receptors are known to influence growth
factor signaling, cell adhesion, and enzymatic catalysis on human cells. Thus, this interaction may be one of
the deciding factors for disease progression in humans infected with HIV-1. In Aim 1, a library of synthetic HS
tetrasaccharides will be screened for binding to human immunodeficiency virus type 1 (HIV-1) p17 protein to
identify the sequence-specific HS characteristics of the preferred binding oligomers. In Aim 2, the HSBP-HS
complexes of both strong and weak binding sequences will be studied via nuclear magnetic resonance (NMR)
to model the structure of the complex and identify key interactions for future drug development. After the
methodology is established, HS-binding chemokines will be screened in Aim 3 to identify suitable targets for
future NMR studies.

Public health relevance
Project Narrative Glycosaminoglycans (GAGs) are expressed ubiquitously on mammalian cell surfaces and interact with a wide variety of biological molecules to modulate processes, including immune response, regulation of cell growth and blood-stream clotting. Disruption of GAG-binding has the potential to prevent infection by viruses, such as HIV-1, and to reduce inflammation caused by autoimmune disorders. This project will utilize recently developed synthetic GAG libraries and NMR-based structural models to develop a pipeline to identify key interactions between heparan sulfate and heparan sulfate binding proteins, which can be used as a basis for development of drugs to target and disrupt GAG-protein binding.